Energizing and Protecting Axons Through Metabolic Coupling to Schwann Cells

Axons and their associated glia (Schwann cells and oligodendrocytes) form the largest part of the neuronal
network. Axons are challening to maintain energetically and are vulnerable to a wide spectrum of noxious stimuli.
Dysfunction of axons and pathological axon degeneration (pAxD) have emerged as a major pathophysiological
driver in many neurodegenerative diseases. Consequently, a central therapeutic focus is to develop approaches
tailored to protect axons. A prerequisite for such therapies is a better understanding of the autonomous and non-
cell autonomous molecular mechanisms that regulate the processes leading to pAxD. Physical disconnection of
the axon from the neuronal cell body is a widely-used experimental platform that has dramatically improved our
understanding of these processes over the last two decades. Primarily studied in the peripheral nervous system
of vertebrates, this paradigm triggers early injury responses in Schwann cells followed by rapid and stereotyped
disintegration of axons (Wallerian degeneration). It is now known that axon disintegration is evoked by a
conserved auto-destruction program that exhausts axonal ATP content through rapid depletion of the metabolic
cofactor NAD+ in disconnected axons. Importantly, recent studies indicate an instructive role of axonal
bioenergetics for the survival of injured axons. Given that neurodegenerative diseases are broadly associated
with axonal bioenergetic defects, these findings suggest that the decline of axonal bioenergetics occupies a
central position in the pathway leading to pAxD. In support of this, we recently made the exciting discovery that
Schwann cells convert their energy metabolism early upon axon injury to antagonize the structural breakdown
of injured axons, likely through the increased supply of glycolytic end-products (axon-glia metabolic coupling).
Furthermore, we found that the manipulation of the metabolic injury adaptation in Schwann cells accelerates or
delays the degeneration of perturbed axons in acute and subacute pAxD models. For the first time, this
demonstrates a non-cell-autonomous energetic mechanism that controls the fate of injured axons. The first aim
of this proposal attempts to determine if the suggested metabolic coupling mechanism counteracts the energetic
decline of injured axons through the enhanced supply of glial manocarboxylates that support axonal ATP
production. The next objective extends the identification of the key components of the metabolic coupling
pathway critical for the support of injured axons with an emphasis on axonal mitochondria. The final goal intends
to examine as to how manipulation of metabolic coupling influences pAxD in an iatrogenic disease model of
subacute axon pertubation. Collectively, this work has the potential to introduce a paradigm shift away from
neuron-centric views of axon protection. The proposed efforts may open the door for the future development of
novel therapeutic approaches taking into account the relationship between axonal and glial bioenergetics to
combat pAxD in neurodegenerative disorders.
.

Public health relevance
Pathological axon degeneration is a hallmark of many neurodegenerative conditions. We recently discovered that Schwann cells, the glia of the peripheral nervous system, protect injured axons through a metabolic coupling mechanism which likely supports axonal bioenergetics. The main goal of this proposal is to examine how manipulation of metabolic coupling regulates axonal bioenergetics, thus impacting the survival of axons after acute and subacute injuries.